U-RISE at University of Maryland Baltimore County

PROJECT SUMMARY/ABSTRACT
The purpose of this application is to renew the University of Maryland Baltimore County's (UMBC) current
Undergraduate Research Initiative for Student Enhancement (U-RISE) training grant, (T34GM136497, U-RISE
at University of Maryland Baltimore County) and obtain funding for an additional five years to continue to support
research training of 35 trainees per year. During the first 4 years of the current grant 108 students have been
supported by the program with 93% of the 73-students graduating with a B.S in STEM and 60% matriculating
directly into either a Ph.D. or M.D. / Ph.D. program, this is 4 times higher than a control group.
The aim of U-RISE is to develop a diverse pool of undergraduates who complete their baccalaureate degree,
and transition into and complete biomedical, research-focused higher degree programs (e.g., Ph.D. or
M.D./Ph.D.) and pursue biomedical research careers. All qualified students with a strong commitment to
diversity, equity and inclusion are welcome to apply. Because evidence suggests that participation in the field of
biomedical research by historically underrepresented groups can help to alleviate existing health disparities,
applicants with backgrounds and life experiences that are underrepresented in science, technology, engineering
and mathematics (STEM) are encouraged to apply; specifically, racial and ethnic minorities, students of low
socioeconomic status, and students with disabilities. The program will provide activities to assure: (i) excellence
in academic science, (ii) understanding and adapting to the intensity and rigor of contemporary scientific
research, (iii) student interest in pursuing a Ph.D. or M.D/Ph.D. degree and a career as a researcher in the
biomedical, behavioral, and mathematical sciences, as well as (iv) selection of graduate school, and developing
successful admission applications, and (v) an emphasis on student mental health and wellness. U-RISE at
UMBC will provide comprehensive financial support to ensure that trainees can focus on preparing for a smooth
and successful transition from UMBC to competitive graduate programs at highly ranked institutions. Students
with relevant majors will be recruited from UMBC and community colleges during the first semester of their
sophomore year, and successful applicants will be appointed to U-RISE in April. Admission eligibility will require
a 3.2 cumulative GPA, a minimum of 60 college-credits, and commitment to a research career. Trainee
participation will begin with a summer research internship and continue in the junior and senior academic years
with academically challenging courses, plus 8-10 hours per week in sustained research with a faculty mentor at
UMBC or a nearby institution. The 2–3-year program also consists of required development courses (i.e.,
professional development, scientific writing, rigor and reproducibility, research ethics and policy) designed
specifically for U-RISE participants. Program design and participant selection will be guided by the U-RISE
Advisory Committee and administered by the U-RISE Program Director) with the assistance of the full-time U-
RISE Associate Director.

Public health relevance
PROJECT NARRATIVE The goal of U-RISE at UMBC is to develop a diverse pool of undergraduates who complete their B.S degree and Ph.D. or M.D./Ph.D. in biomedical science. Increasing diverse perspectives within the biomedical research workforce will maximize potential for scientific problem-solving.